AR signal mediators in prostate cancer

Androgen signaling through androgen receptor (AR) plays a pivotal role in control of cell proliferation and differentiation in the development and progression of prostate cancer. AR, a hormone regulated transcription factor, regulates dynamic gene expression programs. However, how the function of AR is altered from its pro-differentiation in normal prostate epithelium to pro-proliferation and tumor growth in prostate cancer is poorly understood. Through functional genomics, we have uncovered a novel nuclear ATPase coregulator protein that physically and functionally associates with AR and other key cell signaling regulators. Strikingly, this coregulator is induced by androgen in androgendependent cancer cells, highly expressed and possibly amplified in androgen-independent cells and tumors. Our preliminary studies also reveal that it plays very unique functions by specifically mediating the pro-proliferation and survival signaling pathways in prostate cancer cells and, at the same time, suppressing the androgen-induced differentiation program. Taking together, we hypothesize that this coregulator is a key mediator of specific AR function in AR's tumorigenic signaling through its dualistic switch mechanism and that its aberrant function represents an important mechanism of the conversion of prostate cancer to the hormone-refractory state. To test our hypothesis, we propose to establish its role in prostate cancer cell cycle progression, cell survival and invasion and define the specific signaling pathways integrated by this AR coregulator. To examine its function in a physiologically relevant setting, we will determine how its aberrant function affects tumor growth and progression to hormone deprivation therapy resistant status. The completion of the proposed study will provide new insights into the molecular underpinnings of AR-mediated tumorigenic signaling in prostate cancer and lead to a novel therapeutic strategy in treatment of the disease.

Public health relevance
Hormones such as androgen play crucial roles in the normal growth and function of prostate and in prostate cancer. These biological effects are largely mediated by the hormone receptor or specifically the androgen receptor (AR). AR functions primarily by controlling specific gene expression, which in turn elicits specific biological signaling events to either promote differentiation or promote growth and cell proliferation. In normal adult prostate, AR primarily controls cell differentiation. However, in prostate cancer, the function of AR is switched from pro-differentiation to pro-proliferation. Currently, it is still poorly understood how in prostate cancer AR function is abnormally switched. We have uncovered one of the master regulators of tumor cell function. Our findings made so far suggests that this novel master regulator is likely to be one of the switch proteins. This proposed study will examine how this nuclear switch protein works together with AR to selectively mediate AR's pro-proliferation and other tumorigenic function and at the same time suppress AR's pro-differentiation function. Understanding the process will provide novel insights to the underlying molecular mechanisms of prostate cancer progression from hormone-sensitive to hormone refractory status, which will be valuable to the design of new treatment regimens. As the novel protein has an enzymatic activity and its level is highly elevated in prostate cancers, studying how it functions will also provide molecular basis for targeting this new protein.